Research Capacity Core

ABSTRACT
RESEARCH CAPACITY CORE
The RCMI AXIS Program at CDU is designed to address health disparities by researching diseases that affect
the community it serves and creating technologies and research infrastructure to serve the institutional scientific
community and its academic and community partners. The Research Infrastructure in CDU’s AXIS Center is
designed to develop technology and infrastructure for investigators/researchers/students conducting leading-
edge translational research to improve health and eliminate health disparities. In the last funding cycle (2019-
2023), we established the Research Infrastructure Core (now called Research Capacity Core [RCC]) at CDU
through a combination of institutional funds, previous AXIS/RCMI/NIMHD funding support (2009-2014 and 2014-
2019), other Center grants, and Endowment funds. The Core integrated our resources in Laboratory Technology,
Genomic, Pretomics, Sequencing Technology, Drug Discovery, Informatics, Methodology, Statistics, and Clinical
Research Resources into one transdisciplinary infrastructure Core focusing on Precision Medicine and Precision
Health.
The RCC aims to overcome the lack of inclusion of ethnic minorities and socially disadvantaged populations in
the resource-intense era of genomic research by providing services and training to CDU investigators on next-
generation sequencing technology, genomics, and bioinformatics. The transdisciplinary RCC in our AXIS Center
can provide resources supporting genomic/epigenomic research linking with upstream social determinants of
health factors to understand the impact of social and neighborhood environment on health outcomes in our
community that is critical for developing the future precision health workforce for African American and Latinx
community in South Los Angeles. The RCC at CDU has been used widely by investigators and supported three
funded complete Projects, pilot projects, and AXIS supplement projects in the last cycles. In this renewal
application, the RCC will continue to strengthen research infrastructure, focusing on Precision Medicine, to apply
to various disciplines in CDU to benefit researchers and research Projects in social, behavioral, genomic,
epigenomic, clinical, and community outreach research related to health disparities, health equity, and precision
health.